BMPR2, Monocytes and Macrophages in Pulmonary Artery Hypertension

Our studies pursue exciting new data supporting the hypothesis that the circulating monocyte (MON) and its
derivatives, the MON-derived dendritic cell (MO-DC) and the MON-derived macrophage (MO-MØ) orchestrate
a chronic innate immune response that underlies the progressive occlusive vascular pathology in pulmonary
arterial hypertension (PAH). In Aim 1, we relate a reduction in BMPR2, the most frequently mutated gene in
PAH, to an increase in the retroviral element HERV-K in MON. We extend new findings in MON suggesting that
reduced BMPR2, through a DNA repair response, increases phosphorylated KAP1, resulting in transcriptional
activation of XIST, the lncRNA that inactivates the X chromosome. We elucidate whether the increase in XIST
competitively recruits the deacetylase SPEN away from HERV-K, resulting in an increase in HERV-K expression
and consequent viral innate immune interferon (IFN)-STAT1 signaling. We determine whether this is a feature
of MON in all forms of PAH, particularly in females, and persists in PAH MO-DC and MO-MØ. We investigate
whether the propensity to apoptosis in PAH MON is related to IFN-STAT1 signaling and results in differentiation
of surviving MON that invade pulmonary arteries to become pro-inflammatory MO-DC and MO-MØ. In Aim 2,
we add MON differentiated from induced pluripotent stem cells (iPSC) (iMON) to novel bio-fabricated vascular
tubes perfused under physiologic or high shear stress and populated with iPSC-differentiated endothelial cells
(iEC) lining the lumen surrounded by circumferentially arranged iPSC-differentiated smooth muscle cells (iSMC)
derived from PAH patients carrying a BMPR2 mutation or from control subjects. Single cell RNA Seq is applied
to find mechanisms explaining (i) differentiation of iMON to iMO-DC and iMO-MØ, (ii) iMO-DC induced iSMC
proliferation, and (iii) iMO-MØ impaired phagocytosis. Monocytes from athymic rats treated with SUGEN 5416
where females develop more severe PAH than males, and Bmpr2+/- rats treated with 5-lipoxygenase that develop
PAH with no gender bias will be assessed for the innate immune response observed in human PAH MON. Two
strategies will be used to trace MON differentiation to MO-DC and MO-MØ during the evolution of PAH in the
rats and we will determine whether blocking IFN prevents pulmonary vascular remodeling and PAH. In Aim 3
CRISPR inhibitory technology is applied in which iPSC expressing dCAS9KRAB are differentiated to iMON and
transduced with guides targeting a reduction in 9 genes expressed in MON and mutant in PAH. We will determine
whether these cells share a common pathway of gene dysregulation. Bio-fabricated vascular tubes populated
with iEC and iSMC with a reduction in these PAH genes are used to determine the contribution of mutant vascular
cells to iMON differentiation to iMO-DC and iMO-MØ. Genome wide CRISPR screens are applied to find
regulators of HERV-K expression and agents that improve PAH MØ phagocytosis. By uncovering the
mechanism causing an innate immune response in MON, MO-DC and MO-MØ, we aim to find new ways to treat
PAH and conditions associated with a protracted innate immune response, e.g., related to IFN-STAT1 signaling.

Public health relevance
NARRATIVE: We investigate the innate immune mechanism underlying the activated circulating monocyte in pulmonary arterial hypertension (PAH) and its pivotal role in orchestrating adverse vascular remodeling through its derivatives, the monocyte derived dendritic cell (MO-DC) and the monocyte derived macrophage (MO-MØ). Our studies include bio-fabricated vascular tubes with monocytes and vascular cells derived from patients with BMPR2 mutations as well as transgenic rat models of PAH. We apply CRISPR screens to determine how mutations associated with PAH share pathways of monocyte activation that lead to pathological MO-DC and MO-MØ, and how these features can be addressed in developing new therapies.